Genomic and Bioinformatic Core

GENOMIC AND BIOINFORMATIC CORE – PROJECT SUMMARY
The Genomic and Bioinformatic Core (GBC) will provide CNDD investigators with the resources, support,
and training necessary for both data analysis, data sharing, and data interpretation. The overall objective of
the GBC is to enhance the success of the CNDD investigators through high-quality support in state-of-the-
art bioinformatics, biostatistics, and data management for CNDD research projects and pilot projects through
mentorship and training and analysis execution, which includes assistance with study design,
implementation, data collection, analysis, data publication and sharing, and future grant proposals. The
hardware backbone of GBC computing capacity is a cluster with 200 CPU cores and 2 GPU cores distributed
over 3 nodes with 346 GB RAM each. The software backbone consists of a suite of scientific programming
environments, as well as compilers for all major programming languages, and in-house analysis pipelines
are available for standard NGS sequencing analysis and single-cell multiomics. The GBC will host a Git
repository (GitLab) for software-version control and data sharing to assist the CNDD JIs and their trainees
with bioinformatic data sharing. The GBC will assist CNDD JI success thru the following Specific Aims: 1)
Provide CNDD investigators with essential computation infrastructure for complex genomic and bioinformatic
research approaches; 2) Provide CNDD Investigators with expert technical staff to carry out complex
bioinformatic analysis of genetic, transcriptomic, and epigenomic data sets; and 3) Train and mentor CNDD
investigators, their trainees, and the broader MUSC research community, in cutting-edge, bioinformatic data
analysis of genetic, transcriptomic, and epigenomic data sets.